A Chairside Diagnostic to Reduce the Need for Endodontic Retreatment

The objective of this proposal is a chairside molecular diagnostic to detect Enterococcus faecalis in
endodontic infections and improve root canal outcomes. There are over 15 million root canals in the United
States each year, but this treatment has a failure rate of up to 14%, which requires a repeat (secondary)
root canal with major negative impacts on patients, providers, and budgets. One common reason for root
canal failure is secondary endodontic infection. The bacterium E. faecalis underlies up to 77% of these
secondary infections, and thus tools to detect E. faecalis chairside to confirm site preparation before
closing the root canal could improve outcomes. Unfortunately, E. faecalis is currently only quantified with
lengthy lab-based methods (i.e., PCR, microbiological testing): These cannot be done quickly or chairside,
and clinicians are thus limited to using visual inspection and clinical experience, making secondary
treatment unnecessarily common. We propose here a rapid colorimetric test that uses this pathogen’s
natural protease signature as a trigger to produce signal. The outcome of this work will be a rapid chairside
colorimetric diagnostic that reports the presence of E. faecalis via its characteristic extracellular protease
GelE. This assay will confirm the absence of the pathogen so the canal can be sealed with confidence.
Infected canals would be directed to more aggressive irrigation or treatment prior to filling and sealing the
space. This will also prevent excessive cleaning therefore decreasing the chance of perforation. The
research workflow will include two parts. Aim 1 will build the reagents for colorimetric coccolysin detection.
We will synthesize and screen peptides to optimize the substrate unique to coccolysin cleavage. We will
then use this substrate to tune nanoparticle aggregation/disassembly (and thus a color change) in the
presence of the E. faecalis GelE protease. We hypothesize that the colorimetric signal (i.e., color change)
will increase linearly with protease concentration (p < 0.05). Our goal is to detecting sub-nanomolar
concentrations in less than 10 minutes. Aim 2 will validate the sensor with cultured bacteria and clinical
endodontic samples collected by Dr. Roges. E. faecalis levels in the samples will be measured
independently using PCR by Dr. Chen, and GelE protease concentrations will be confirmed using ELISA.
We hypothesize that the colorimetric signal will correlate to these gold standard metrics at R2 > 0.80. The
clinical impact is a chairside diagnostic to detect E. faecalis and enhance clinician and patient experience
by decreasing the likelihood of secondary endodontic infection. The innovation is grounded is novel
diagnostics for an important clinical scenario as well as novel nano-chemistry approaches that use
nanoparticle disassembly for a color change, thus minimizing the impact of the sample matrix.

Public health relevance
Root canal treatment remains prone to secondary infection because doctors rely on visual inspection or lab- based methods to detect bacterial infection during therapy. This work will build a colorimetric chairside diagnostic to detect Enterococcus faecalis and thus reduce endodontic infection and the need for secondary treatment. The resulting diagnostic will guide site preparation and define when sufficient sterilization has been achieved before sealing the root canal, thus reducing the need for repeat therapy.